Defining Tumor Microenvironment and Response to Immune Checkpoint Blockade in HIV-related Anogenital Squamous Cell Carcinomas (Immuno/microenvironment)

Defining Tumor Microenvironment and Response to Immune Checkpoint Immunotherapy in HIV-related
Anogenital Squamous Cell Carcinomas (Immuno/microenvironment)
ABSTRACT
Scientific Rationale: Human papillomavirus (HPV)-associated cancers are a growing health problem,
especially amongst human immunodeficiency virus (HIV)-positive patients. Despite the decrease in mortality
due to combination antiretroviral therapy, people living with HIV/AIDS (PLWH) continue to experience a high
burden of anogenital HPV-related squamous cell cancers. Predictive markers for patients’ response to specific
therapies are important tools for clinicians in choosing the best anti-cancer therapy for an individual patient.
This includes immune checkpoint immunotherapy (ICI), which is growing in its use in patients with anogenital
cancers. In a preclinical mouse model for HPV-associated neoplastic disease, we recently discovered that
papillomaviruses evade host immunity to establish persistent infections that can lead to cancer by inducing
expression of the host gene, Stress Keratin 17 (K17), thereby suppressing T cell mediated immune
surveillance and anti-tumoral macrophages [1].
Hypothesis: Our central hypothesis is that K17 expression in anogenital squamous cell carcinoma induces an
immunosuppressive tumor microenvironment (TME) with distinct features between HIV+ vs. HIV- patients,
thereby defining their ICI response.
Our multidisciplinary team will systematically test this hypothesis through the following two specific aims:
Project Design:
Aim 1: Test whether K17 is a useful marker for predicting the responsiveness of HPV+/- anogenital (cervix,
vulvar, and anal) squamous cell carcinomas treated with ICI or first-line therapy in HIV+/- patients.
Aim 2. Identify the TME phenotypes of HIV+ /-, HPV+/- anogenital (cervix, vulvar, and anal) cancers.
Relevance: This research proposal will test a novel biomarker of response to ICI in HIV positive versus HIV
negative patients with anogenital cancers and characterize the TME in HIV-associated anogenital cancers to
provide mechanistic insights of the role of K17 on TME, and potentially identify novel targets for ICI.
This is a collaborative P30 Administrative Supplement Application from Drs. Evie Carchman, Megan
Fitzpatrick, Huy Dinh, Nathan Sherer, Paul Sondel, and Paul Lambert. Our multidisciplinary team includes a
junior gynecologic pathologist with experience in HPV molecular virology and dysplasia studies among PLWH
with HIV/AIDS (Co-Project leader: Fitzpatrick), a colorectal surgeon with expertise in the treatment of various
HPV-associated anogenital diseases and expertise in use of mouse anal cancer preclinical models (Co-Project
leader: Carchman), a computational biologist with experience in evaluating complex tumor immune
microenvironments in several cancer types, including HPV-related cancers (Dinh), a researcher with expertise
in HIV (Sherer), a senior expert in HPV infection and HPV-related cancers whose lab has developed multiple
preclinical mouse models for anogenital cancer (Lambert), and a noted tumor immunologist who brings specific
expertise in manipulating levels of CD4 and CD8 cells in mice, which is relevant to our proposed animal
studies (Sondel).

Public health relevance
PROJECT SUMMARY A critical need exists to identify markers of patients' response to immunotherapy and identify novel targets for immunotherapy, especially in patients living with HIV. To address this critical need, this study’s objective is to test whether a marker, K17, is useful in predicting response to immunotherapy in patients with anogenital cancer and to characterize the tumor microenvironment to identify novel targets.